Innate Immunity Across the Molecular, Cellular, Tissue and Therapeutic

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Innate Immunity Across the Molecular,
Cellular, Tissue and Therapeutic, organized by Drs. Kate Jeffrey, Ramnik Xavier and Xu Zhou. The conference
will be held in Alberta, Canada from April 9–12, 2024.
Over three decades ago, Charles Janeway predicted that pathogen sensing was mediated by germline-encoded
pattern recognition receptors that detect conserved pathogen-associated molecular patterns (PAMPs). Since
then, a multitude of endosomal and cytoplasmic sensors, their ligands and downstream signal transduction
pathways that initiate innate immunity have been defined. Emerging techniques such as cellular and spatial
transcriptomics are informing us where in the human body, and in what diverse disease contexts, these pattern
recognition receptors (PRRs) and associated gene circuits are implicated. Furthermore, metabolic and chromatin
analyses are now illuminating acute and chronic adaptation of innate immune cell transcriptional programs. The
next frontier in innate immunity will be understanding how innate sensor-ligand interactions, and the individual
cellular programs that ensue, work in complex systems of tissue and microorganismal microenvironments. Of
particular importance will be grasping innate immunity resolution during homeostasis and how it can be
leveraged, or avoided, for the treatment of infectious, autoimmune, neurodegenerative, cardiovascular and
oncological diseases. This conference will provide multidisciplinary perspectives on new horizons and
unexpected advances in innate immunity. The program will highlight innovative techniques and novel read outs
of innate immunity at the molecular, cellular and tissue level and examine the connections of innate immunity
with human health. The program will also take a deep dive into clinical aspects of disease and contemporary
drug discovery approaches to harness or regulate innate immune using pharmacologic approaches. This
conference is designed to be a unique forum for researchers from diverse and traditionally non-overlapping fields
(immunology, metabolism, artificial intelligence, drug discovery, structural biology), to build fresh ideas and
collaborations for the next chapter of innate immune discovery and translation. Finally, this conference is being
held concurrently with a Keystone Symposia meeting on Systems and Engineering Immunology, which will allow
attendees to interact with colleagues in a related area of immunology.

Public health relevance
PROJECT NARRATIVE The innate immune system is our first line of defense against infection and given the expanding scope of pathogens in our global ecosystem, it has become essential to understand the complex mechanisms of innate immunity. This Keystone Symposia conference will feature the latest insights on pathogen sensing, immune signaling and their connections to health and disease and will highlight the latest technologies for exploring these systems in greater detail. By bringing together researchers from academia and industry, the conference will also provide a unique opportunity to optimize targeting innate immunity pathways to improve human health.